Understanding Ancestral Contribution to Lung Adenocarcinoma

PROJECT SUMMARY/ABSTRACT
Although there are existing epidemiological studies of disparities in cancer incidence and outcomes, there are
very few studies of disparities in cancer genomes, which requires both germline, somatic, and clinical data from
the same patients. However, studying ancestry-specific genomic alterations is one of the most effective ways to
understand the underpinning mechanisms in cancer disparity, and develop potential prevention and therapeutics
strategies. Dr. Carrot-Zhang and others evaluated genetic ancestry effects on somatic alterations among 10,678
patients across 33 cancer types from The Cancer Genome Atlas, and highlighted novel ancestry-specific
evolutionary trajectories from pan-cancer and tissue-specific analyses. We also suggested that ancestry
associations were profoundly tissue specific, and therefore, more samples from diverse ancestries are required
for tissue-specific analyses. To that extent, this proposal is based on large sequencing data sets composed of
1,153 lung cancer patients from Mexico and Colombia, and 60,085 lung cancer samples from Foundation
Medicine. Our overall goal is to understand the well-known, but mysterious, population-specific genomic
differences in lung adenocarcinoma. Our first aim is to systematically characterize the landscape of ancestry
effects on genomic features of lung adenocarcinoma, as we are well powered to detect new associations. Then
in the second aim, Dr. Carrot-Zhang will develop a novel statistical method leveraging the local ancestry
(ancestry of a genomic region) from ancestry-admixed populations to infer the heritability of ancestry-associated
somatic features. We will also explore the potential mechanisms underlying genomic differences related to
ancestry. Our third aim is to elucidate the influence of ancestry on clinical outcome, in order to improve
prognostics and precision medicine for the minority populations.
Dr. Carrot-Zhang’s long-term career goal is to improve cancer prevention, early detection and treatment by
integrating computational biology, germline genetics, and somatic genomics approaches to understand the
mechanisms underlying cancer initiation and progression. The K99 award will further prepare her for a successful
independent research career. Dr. Carrot-Zhang’s training will be carried out under the extraordinary mentorship
of Dr. Matthew Meyerson (cancer genomics), and an advisory committee consisting of Drs. Alexander (Sasha)
Gusev (population genetics and statistical genetics), Rameen Beroukhim (cancer biology), Heng Li
(computational method development), and David Kwiatkowski (clinical oncology). The proposed research plan
will be facilitated by the outstanding institutional environment of the Dana-Farber Cancer Institute and the Broad
Institute. The scientific collaboration with Foundation Medicine will provide exceptional resources for cancer
genomics and ancestry-related analyses. The proposed professional development plan will enhance Dr. Carrot-
Zhang’s career advancement in laboratory management, grant-writing and leadership.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer death in the United States, in part because of our lack of understanding of its etiology, epidemiology, and disparities based on race or ethnicity. Our research aims to characterize the landscape of ancestry effects on lung cancer evolution, and understand the mechanisms underlying the genomic disparities. Our findings will provide implications for lung cancer outcomes and enable the discovery of novel biomarkers to improve prognostics and precision medicine, particularly for the minority populations.